Probiotics for Prevention of Early Childhood Caries

Project Summary
In 2018, we began enrolling young children, ages 1 to 3, in a longitudinal study designed to investigate
changes in the oral microbiome in advance of a caries diagnosis. We included measures of ‘traditional’
(mutans streptococci; MS) and ‘contemporary’ (Candida) cariogens but centered our main focus on non-MS
low pH streptococci. This study remains on track for completion with a more robust data set than originally
estimated due to lower-than-expected attrition. However, Covid-related delays have pushed back the
completion of the study until after the official end of the grant period. For this competitive renewal application,
we examined the current state of the data. As expected, we could not yet draw a conclusion regarding the role
of non-MS low pH streptococci in caries development. However, we came upon an unexpected but exciting
discovery: strains of mildly acidogenic streptococci – that we designated ‘high pH’ strains – were predominantly
found in subjects who remained caries-free during their eighteen months in the study, including one caries-free
subject who otherwise exhibited a cariogenic profile. This distribution of high pH strains is similar to what we
previously observed with a cohort of older children. Several strains from this latter group were evaluated for
desirable probiotic properties and four strains stood out. Strategic Priority #3 from the 2021-2026 NIDCR
Strategic Plan is to “accelerate the translation of research . . . into practices that reduce health disparities.”
This competitive renewal application is designed to do that. We propose to develop our pool of probiotic
candidates by thoroughly analyzing them for their breadth of probiotic qualities, testing their safety, and
developing novel means of age-appropriate and culturally sensitive delivery in preparation for a future clinical
trial to reduce caries incidence in populations that historically experience caries health disparities. The specific
aims of this proposal are to 1) Develop a cocktail of probiotic strains with complementary properties and safety
test in cell culture and animal models; and 2) Develop the most attractive and effective means of delivery for
diverse populations and children of young age. At present, there are few commercial options for probiotics
specifically selected to promote oral health. Completion of the proposed aims will profoundly expand the
repertoire of health-promoting oral probiotics and set the stage for testing an entirely novel approach for
reducing health disparities.

Public health relevance
Project Narrative This project is dedicated to testing candidate strains of microbes, isolated from the mouths of children who have no history of tooth decay, for probiotic properties and safety. Additionally, we will develop novel means of probiotic delivery and explore which are most attractive to potential users.